Blood-to-CNS Drug Uptake in Pain

DESCRIPTION (provided by applicant): Pain is a dominant symptom associated with acute and chronic inflammation. Pain-induced blood-brain barrier (BBB) dysfunction alters CNS delivery of analgesic drugs including opioids. A clear comprehension of biological mechanisms involved in drug transport across the BBB is essential to clarify CNS uptake of opioids and their efficacy in pain treatment. Furthermore, investigation of pathophysiological features of peripheral inflammatory pain (PIP) (i.e., changes in serum concentrations of cytokines such as IL-6 and TGF-2s) will enable an improved understanding of the regulation of drug transporters (i.e., P-glycoprotein (P-gp), Multidrug Resistance Proteins (Mrps), Breast Cancer Resistance Protein (BCRP; also known as ABCG2), organic anion transporting polypeptides (Oatps)) and/or tight junction proteins (i.e., claudin-3 and -5, occludin, ZO-1) at the BBB and how these processes relate to CNS opioid delivery. Additionally, pain management regimens may involve multiple drugs, which can lead to harmful drug-drug interactions. These drug-drug interactions may involve changes in BBB transport mechanisms associated with functional expression of nuclear receptors [i.e., pregnane-X-receptor (PXR), constitutive androstane receptor (CAR)]. The activation of PXR and/or CAR may lead to altered efficacy and/or CNS toxicity of opioids. The ability of nuclear receptors to regulate drug transport may differ between acute and chronic pain. These differences may be related to expression changes in PXR/CAR, which may be associated with variations in serum/cerebrospinal fluid cytokine levels. Our hypothesis is that changes in transport of commonly prescribed opioid analgesics and novel therapeutic opioid peptides will occur due to alterations in the functional expression of putative membrane drug transporters and tight junction proteins. We propose that these changes in transport are caused by cytokine signaling and/or activity of nuclear receptors during PIP. The aims of this grant will be investigated using a combination of in vivo methods as well as biochemical and molecular techniques established and working in our laboratory. This proposal will elucidate mechanisms that can alter CNS opioid delivery and will point to novel strategies to improve PIP treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: PIP may lead to BBB dysfunction, including changes in opioid permeability. This grant application is clinically relevant since PIP-associated changes in BBB xenobiotic permeability can be a factor in altered efficacy and CNS toxicity sometimes observed following opioid administration. This study may point to novel ways to improve CNS opioid delivery and to avoid unwanted opioid side effects during the treatment of pain. Relevance: PIP may lead to BBB dysfunction, including changes in opioid permeability. This grant application is clinically relevant since PIP-associated changes in BBB xenobiotic permeability can be a factor in altered efficacy and CNS toxicity sometimes observed following opioid administration. This study may point to novel ways to improve CNS opioid delivery and to avoid unwanted opioid side effects during the treatment of pain. __SpecificAimsTextDelimiter__ Program Director/Principal Investigator (Last, First, Middle): Davis, Thomas P. Blood-to-CNS Drug Uptake in Pain. Specific Aims For the past twenty years, our laboratory has studied the uptake of opioids across the blood-brain barrier (BBB) and into the CNS. Structural and chemical modifications to these opioids (i.e., halogenation, poly(ethylene) glycol conjugation, Pluronic(R) P85 block copolymer co-administration, glycosylation, amino acid substitution, cationization) were examined to improve their pharmacokinetic and pharmacodynamic characteristics. We have also tested BBB permeability of prodrugs and various stereoisomers of opioid analgesics. Furthermore, we have shown that pathological characteristics of Peripheral Inflammatory Pain (PIP) (i.e., peripheral edema, changes in serum cytokine concentrations, acute neuronal activity, hyperalgesia) are associated with altered BBB cytoarchitecture (i.e., changes in tight junction (TJ) protein expression and drug transporter functional expression) that lead to changes in CNS opioid drug delivery. An understanding of opioid BBB permeability is essential since CNS concentrations of these drugs must be carefully regulated for a clinically relevant analgesic effect and to prevent unwanted side effects. Our studies are significant because they have clarified various interactions of opioids (particularly opioid peptides) with the BBB and have proposed mechanisms by which BBB permeability of peptide therapeutics can be improved. However, specific mechanisms involved in regulation of drug transport across the BBB and how changes in drug transporters and TJ proteins affect CNS delivery of opioid analgesics remain unclear. The goal of this proposal is to investigate effects of PIP (using an in vivo rodent model) on BBB permeability and endothelial cell cytoarchitecture and to determine the effects of PIP on CNS delivery of opioids. Additionally, drug-drug interactions involving drug transporters and/or intracellular signaling involved in the endothelial cell response to PIP will be characterized. These studies are clinically relevant since disease-associated changes in BBB xenobiotic permeability may be a factor in CNS toxicity of analgesic drugs. We hypothesize that changes in the transport of opioid analgesics into the brain will occur due to alterations in the biochemical and molecular structure of the BBB caused by fluctuations in biological mediators (i.e., cytokines) and/or activation of nuclear receptors (i.e., pregnane-X-receptor (PXR) and constitutive androstane receptor (CAR)) during PIP. This study will enable us to delineate signaling systems involved in altering drug transporters and/or TJ proteins at the BBB and, therefore, determine mechanisms that may be targeted to alter the CNS delivery of opioids. To investigate this hypothesis, we propose 3 specific aims: 1. Investigate drug transport properties of opioid analgesics at the BBB during PIP using in situ brain perfusion: The effects of PIP on BBB transport mechanisms such as paracellular diffusion and active transport will be studied using radioactive tracers or drugs over a time course of 1-72 hours following peripheral administration of an inflammatory agent (λ-carrageenan). Transport mechanisms involved in CNS uptake of commonly prescribed opioid analgesics (i.e., codeine, morphine) and novel therapeutic opioid peptides (TY-005, TY-027) during PIP will be determined. Capillary depletion analyses will be performed to indicate whether perturbations in BBB permeability lead to increased drug accumulation in the CNS or are due to trapping within the endothelium. These data will provide evidence of CNS delivery of opioids via different transport routes during PIP. 2. Investigate inflammatory mechanisms involved in modulation of drug transport proteins in cerebral microvessels during pain: Structural, molecular, and biochemical changes in the BBB may contribute to alterations in drug transport. A number of factors will be studied in the context of PIP over the time course described in Specific Aim 1 including a) BBB expression of TJ proteins (claudins, occludin, ZO-1/2/3), ATP- binding cassette (ABC) membrane efflux transporters [i.e., P-glycoprotein (P-gp), Multidrug Resistance Proteins (Mrps), Breast Cancer Resistance Proteins (BCRP; also known as ABCG2)], and organic anion transporting polypeptide (Oatp)1a4 (using western blot analyses and quantitative PCR); b) localization of these proteins in BBB microvessels (using confocal microscopy); c) levels of pro- (i.e., IL-6) and anti-inflammatory (i.e., transforming growth factor (TGF)-ss1) mediators in serum and cerebrospinal fluid (using ELISA methodologies); d) signal transduction cascades pertaining to these mediators (i.e., TGF-ss and IL-6 mediated pathways) (using western blot analysis, confocal microscopy, and chromatin immunoprecipitation (ChIP)); and e) protein phosphorylation changes in brain microvessels (using alkaline phosphatase treatment and western blot analyses). These data will reveal mechanisms that alter endothelial cell cytoarchitecture and lead to changes in drug delivery and/or CNS toxicity of opioids during PIP. 3. Investigate mechanisms of drug-drug interactions in cerebral microvessels that can alter drug delivery to the brain during PIP: It has been estimated that approximately 60% of drug-drug interactions may PHS 398/2590 (Rev. 11/07) Page 1 Continuation Format Page Program Director/Principal Investigator (Last, First, Middle): Davis, Thomas P. involve nuclear receptors such as PXR and/or CAR. Therefore, the role of PXR and CAR in drug-drug interactions involving opioid analgesics will be studied in the context of PIP over the time course described in Specific Aim 1 (figure 1). Using dexamethasone, a glucocorticoid commonly used in the treatment of inflammatory disease and a known PXR ligand, and/or acetaminophen, a non-steroidal anti-inflammatory drug and CAR ligand, the effects of PXR and CAR activation on BBB transport of opioids will be assessed using radioactive tracers (i.e., in situ perfusion experiments). Furthermore, molecular expression and functional activity of PXR/CAR will also be assessed in animals treated with exogenous cytokines (i.e., IL-6, TGF-ss1). Changes in mRNA and protein expression of drug transporters and TJ proteins will be determined by quantitative PCR and by western blot analysis respectively. Binding of nuclear receptors to the promoter region of drug transporter genes and/or TJ protein genes will be assessed using ChIP. These data will provide evidence of a change in CNS delivery of opioids in response to pharmacotherapy of PIP and provide a mechanism for drug-drug interactions that may occur during the treatment of PIP. Nuclear Receptor Ligand (i.e., Dexamethasone- PXR, acetaminophen- CAR) Blood + occludin ZO-2 7H6 ZO-1 ZO -2 ZO-1 ZO-2 actin Brain Endothelial Cell AF-6 ZO-1 claudin 3/5 ZO-1 cingulin JAM Adapted from Hawkins & Davis (2005) Pharmacol Rev. 57: 173-185. Brain Tight Junction Inflammatory Cytokines Altered Transport of TGFsss IL-6 Opioids Apical Regulation of nuclear receptor expression PXR/CAR RXR RXR + ABC Efflux Oatp Transporters Isoforms ? Nucleus ABC Efflux + Oatp Transporters Isoforms Basolateral Altered Transport of Opioids Figure 1: Proposed role of nuclear receptors in the regulation of drug transport proteins involved in the CNS delivery of opioids. The involvement of PXR and CAR on the modulation of ABC efflux transporters (i.e., P-gp, Mrps, ABCG2) and Oatp isoforms (i.e., Oatp1a4) will be investigated in the context of PIP as described in Specific Aim 3. Furthermore, we will also investigate the role of these nuclear receptors in the regulation of tight junction proteins at the BBB and, by extension, paracellular diffusion of opioids. PHS 398/2590 (Rev. 11/07) Page 2 Continuation Format Page